Predoctoral Training Program in Immunology

Studies of the immune system over the last hundred+ years have demonstrated its critical importance to
defense against pathogens and toxins; its role in asthma, allergy and autoimmunity; and more recently how it
can be harnessed in the treatment of cancer. The routine appearance of viral, bacterial, and parasitic
outbreaks all point to the need for the development of new or better immune-based vaccines and a need for
better understanding of how the immune system controls or contributes to disease. Likewise, recent work in
Immunology has increased our understanding of how the microbiome can contribute to or regulate
autoimmune as well as infectious disease, how immunoparalysis alters long-term outcomes after sepsis and
other diseases, and how manipulation of immune checkpoints can boost the immune response. Collectively
these and other immune based studies have had a major impact on human health and led to the discovery of
new therapies and vaccines. Thus, in order to continue recent advancements, discover new therapies, prepare
for future pathogen outbreaks, and educate both medical professionals as well as the public, there is a distinct
need to continue to train the next generation of immunologists. The overall goal of the University of Iowa
Predoctoral Training Program in Immunology is to educate, train, and produce a new generation of excellent
young immunologists, well-prepared to advance the science of immunology and their own independent careers
in academic, educational, and industrial settings. This is a competitive renewal application for years 26-30 of a
training program supporting students pursuing doctoral studies in basic and translational immunology at The
University of Iowa. Thirty-one training faculty members provide intensive laboratory research training and
effective, relevant classroom instruction leading to the Ph.D. or the combined M.D. Ph.D. degree in
Immunology. The diversity of faculty research expertise within the discipline of immunology is a strength of the
training opportunities provided, and is complemented by a network of frequent and successful collaborations in
funding, publication, and student training. We continue to revise and optimize our Program to best meet the
needs of trainee scientific careers and the diverse scientific workforce of the future. This program fills a critical
need to support our continuing efforts in training predoctoral students from diverse backgrounds for
independent careers as immunologists.

Public health relevance
The immune system provides humans with critically important protective responses to infectious pathogens such as viruses and bacteria, as well as to tumor cells; but inappropriate immune responses can also cause inflammation and autoimmune diseases. Studies that advance understanding of immune responses, and how to apply this knowledge to preventing and treating human diseases have great potential to reduce the disease burden and promote the health of the nation. The Predoctoral Training Program in Immunology is designed to provide rigorous training in a supportive environment for graduate students to pursue multiple approaches to understanding the mechanisms underlying immune responses, and apply this knowledge toward the treatment of human disease.